PHASE 1 STUDY OF HIGH DOSE PROCHLORPERAZINE AND CONTINUOUS INFUSION

Prochlorperazine with doxorubicin has been shown to be one of the most effective agents in enhancing chemotherapy drug activity. It has been found to be safe and effective in patients w/ documented drug resistance. Infusional DOX therapy may be more effective than a rapid injection; hence we propose to administer the same dose of DOX as a 48-hr infusion. To assure persistent high blood levels of PCZ a second infusion will be administered on the second day. If administration of a second infusion proves safe, the dose will be escalated to MTD.